RETROSPECTIVE REVIEW OF RADICAL PROSTATECTOMY PATIENTS AT BWH

The purpose of this study is to retrospectively review the outcome and survival in patients undergoing radical prostatectomy. Specifically, survival, freedom from disease, incidence of incontinence and impotence.